ADMINISTRATIVE CORE

The Administrative Core provides a cohesive administrative structure for scientists and support staff on the Program Project. Specifically, the Administrative Core provides 5% support for the Core Leader's effort to coordinate administrative activity of all Program Project personnel with the business administrator. In addition, the Administrative Core provides for support staff who will work closely with all Program Project personnel. The support staff on this Administrative Core prepares all manuscripts and abstracts for scientific meetings, arranges and schedules weekly meetings of Program Project investigators, monitors all grant expenditures and ensures compliance with NIH guidelines, provides monthly financial statements to investigators and orders all material necessary for scientific research.